Using big data to develop universal and selective suicide prevention strategies

BACKGROUND: Suicide confers a massive burden to individuals and society, accounting for nearly 20
Veteran deaths every day. After controlling for age, Veterans’ suicide risk is 22% higher than US adult civilians.
In response, the US Department of Veterans Affairs (VA) has made suicide prevention its first priority. The
VA’s suicide prevention framework prioritizes patients at the highest risk for suicide, including those who
previously attempted suicide, were recently released from inpatient mental health treatment, or use opioids.
Although this strategy has led to improvements for high-risk patients, the majority of patients that die by suicide
are not included in this group. Indeed, less than 3% of recent VA suicide deaths were classified as high-risk by
the leading prediction metric. This proposal specifically focuses on this “non-high-risk” majority, i.e., those who
died by suicide, but whose risk was not detected by existing prediction mechanisms. This proposal leverages
big data to better identify, track, and treat this critical population. It has the potential to have a large impact on
Veteran health, broadening the reach of effective suicide prevention services.
OBJECTIVES: The long-term goal is for the candidate, Dr. Maxwell Levis, to become an independent clinical
researcher focused on developing, testing, and improving suicide prevention resources. His short-term
goals are to: 1) acquire skills in population-based approaches to suicide prediction and prevention, 2) improve
machine learning and natural language processing ability, and 3) gain experience adapting suicide prevention
resources. His research objectives align closely with these goals. Dr. Levis’ proposal’s central hypothesis is
that, through leveraging big data, he can better understand non-high-risk suicide decedents, and, in turn,
develop targeted suicide prediction and prevention mechanisms. In the award’s last two years, Dr. Levis will
submit a VA Merit Award proposal on leveraging psychotherapy to decrease suicide risk in this population.
METHODS: The VA’s suicide prevention framework relies on universal strategies to reach all patients (low-
risk), selective strategies to reach some patients (moderate-risk), and indicated strategies to reach the
relatively few patients with symptoms associated with suicide (high-risk). While strides have been made for
indicated strategies, comparable achievements have not been made for universal and selective strategies.
Using Corporate Data Warehouse data, Dr. Levis will develop a dataset of recent (2017–2018; n ≈ 4000) non-
high-risk suicide decedents (cases) and characterize this sample’s demographics, service and mental health
usage, and risk and treatment factors. He will then develop a suicide risk-matched (1:[10]) sample of VA
patients that did not die (controls), but shared similar risk, services, demographics, location, and treatment
intervals. Dr. Levis will then leverage cases’ and controls’ structured and unstructured electronic health record
(EHR) data to develop machine-learning-derived suicide-prediction models. He will also sub-select non-high-
risk patients that received psychotherapy in the year before death by suicide (n ≈ 2,750) and risk-matched
controls that did not die (1:5), but shared similar risk, psychotherapy usage, [pharmacotherapy], demographics,
location, and treatment intervals. Dr. Levis will use time-sensitive machine learning methods to evaluate
changes in psychotherapy note text over time, tracking change mechanisms, intervals of heightened changes,
and domains associated with reduced suicide risk. These findings will support a subsequent investigator-
initiated research proposal using derived information to leverage psychotherapy to reduce suicide risk among
Veterans.
IMPACT: The goal of this award is to help Dr. Levis become an independent clinical researcher in the suicide
prevention field. This award consists of educational, research, and mentorship components. Education
components will center on analytic and clinical research skills. Dr. Levis will receive mentorship from suicide
prevention and clinical research leaders. These areas will be central for Dr. Levis’ Merit Award proposal.

Public health relevance
While the VA has made considerable progress in predicting and preventing suicide for patients at the highest risk—including those who previously attempted suicide, were recently released from inpatient mental health treatment, or use opioids—no comparable achievements have been made for patients in lower-risk tiers. Indeed, even though they constitute the vast majority of VA suicide deaths, very little is known about VA patients who die by suicide but are not identified as being at high-risk by existing programs. The proposed study is highly relevant to Veterans’ health because it will advance epidemiological understanding and targeted prediction and prevention resources for these non-high-risk suicide decedents. This work would be highly scalable and could have a large positive impact on Veterans’ health by preventing suicide in patients whose risk otherwise would go undetected. The proposed research is highly relevant to the VA’s top clinical priority, aiding development of accurate and effective suicide prevention services that reach deeper into the risk pool.